Nicotine and NLRP3 Inflammasome in HIV-1-Associated CNS Inflammation

PROJECT SUMMARY
Human immunodeficiency virus type 1 (HIV-1) infection remains incurable, with over 38 million people affected
worldwide. While HIV-1 is known to enter the brain within the first two weeks of infection, it is estimated that 20-
50% of people with HIV-1 will develop HIV-associated neurocognitive disorder (HAND). Neuroinflammation is
thought to play a key role in HIV-1 persistence, and substance use disorders, including smoking, may further
contribute to inflammation and cognitive decline. In this study, we aim to investigate the impact of nicotine, a key
component of tobacco smoking, on NLRP3 inflammasome activation in the central nervous system of people
with HIV-1 and substance use disorders. Our research addresses a critical gap in understanding how
inflammation contributes to HIV-1 persistence and cognitive decline in smokers with HIV-1. We will investigate
how HIV-1 infection and nicotine exposure interact to activate the inflammasome and increase inflammation in
human tonsil explants and iPSC-derived microglia to achieve our goals. We will use a newly developed xenograft
humanized mouse model to track inflammasome differential expression and activation in brain regions,
specifically in latent and productively infected and bystander cells. Finally, we will analyze post-mortem brain
samples from individuals with HIV-1 and compare the expression of markers associated with NLRP3
inflammasome activation in smokers versus non-smokers. The proposed research will provide crucial insights
into the mechanisms underlying neuroinflammation and cognitive decline in people with HIV-1 and substance
use disorders. Our work will elucidate the role of NLRP3 inflammasome activation in HIV-1-associated
inflammation and identify potential therapeutic targets to address this issue. By advancing our understanding of
inflammation and the immune response to HIV-1 in smokers, we hope to develop novel treatments for this
population's cognitive decline and immune dysregulation.

Public health relevance
PROJECT NARRATIVE Human Immunodeficiency Virus (HIV-1) causes a chronic, incurable infection, and while existing therapies can suppress the virus, people with HIV develop more comorbid conditions than uninfected individuals. This proposal aims to investigate the impact of nicotine on NLRP3 inflammasome activation in people with HIV and substance use disorders by infecting human tonsil explants and iPSC-derived microglia with HIV-1, and characterizing how nicotine impacts HIV latency and the activation of inflammasomes in CNS cells, and using scRNAseq on post- mortem brains. The study team has extensive expertise in HIV virology, inflammasome biology, and substance use disorder, and successful completion of the proposed studies will inform future therapeutic targeting of the NLRP3 inflammasome in mitigating the inflammatory sequelae associated with HIV and nicotine use.